ECOG-ACRIN NCORP Research Base

Project Summary
The ECOG-ACRIN Cancer Research Group (EA) is dedicated to decreasing the burden of cancer. EA
is a vibrant member of the National Clinical Trials Network (NCTN) and the NCI Community Oncology
Research Program (NCORP), focused on practice-changing clinical and translational research across
the cancer care continuum from prevention and early detection, through the management of advanced
disease and its impact. As an NCORP Research Base, EA has engaged community providers and
researchers to develop a robust research portfolio that spans Cancer Prevention, Cancer Control, and
Cancer Care Delivery, aligned with the overall scientific themes of precision oncology, immuno-oncology,
reducing overdiagnosis and overtreatment, and leveraging novel biomarker platforms. Cancer control
trials examine and intervene on challenges associated with cancer and treatment-related symptoms and
concerns. EA's portfolio of therapeutic trials yield opportunities to apply patient-reported outcomes
measurement science to quantify health-related quality of life, symptoms, and domains most relevant to
patients in the context of evolving treatment paradigms. Behavioral and biomarker-driven symptom
interventions aim to improve quality of life and cancer survivorship. Cardiotoxicity research aims to
mitigate risk through quantifying cardiotoxicity associated with treatment, identifying groups at risk, and
advancing interventions to reduce risk. Prevention trials embrace the NCI's broad definition of prevention
to include primary prevention, cancer screening, and secondary prevention and aim to identify high risk
groups for precision prevention strategies. Cancer Care Delivery Research (CCDR) examines the
complex interactions between patient, provider, and system factors that influence care, and adapts and
evaluates interventions in heterogenous community oncology practices. Health equity research
permeates EA science through embedding disparities-related research questions that span EA activities,
adopting a broad view of underserved populations including adolescents and young adults, the elderly,
racial and ethnic minorities, sexual and gender minorities and rural residents. Key collaborations with
community-based oncology programs will ensure access to EA NCTN and NCORP trials in communities
where patients receive their care. EA provides access to existing NCI-funded resources and a network
of >10000 physicians, scientists, nurses, research associates (RAs), statisticians, biomedical information
technologists, and patient advocates across approximately 600 institutions and organizations. EA has
provided scientific leadership in the NCORP community through advancing rigorous, practice-changing
clinical trials and translational research in cancer control, prevention and care delivery and is well poised
to continue to support the NCI's mission to engage community-based diverse populations in cancer
research.

Public health relevance
Project Narrative The primary goals of the ECOG-ACRIN NCORP Research Base are: 1) to advance our understanding of approaches to prevent cancer and cancer-related physical and psychological symptoms, and 2) to develop and evaluate strategies to translate advances in high quality cancer care delivery into community oncology settings, with the aim of reducing the burden of cancer.